The Role of Leiomodin1 in Hypoxic Neovessel Maturation

PROJECT SUMMARY
Peripheral artery disease (PAD) is a severe form of cardiovascular disease (CVD) affecting > 230
million individuals worldwide. Given the compelling evidence that PAD is a consequence of diminished blood
flow in one or more major arteries of the limb, the expectation has been to develop therapies designed to
stimulate the formation of new mature blood vessels to restore blood perfusion. However, despite years of
investigations, the advent of medical therapies designed to improve blood perfusion to the distal limb have
proven to be of limited benefit, due in large part to a lack of understanding of the underlying molecular
mechanisms involved in the formation of mature neovessels. Interestingly, while pursuing the goals of an
alternate proposal aimed at determining the role of Leiomodin 1 (LMOD1), a CVD genome wide association
study target gene preferentially expressed in smooth muscle cells (SMCs), in the pathogenesis of
atherosclerosis, this investigator led team found that mice with reduced Lmod1 expression demonstrate
increased plaque hemorrhage owing to rupture of the neovasculature within the plaque. While this study
illustrates the potential role of Lmod1 in the formation of mature neovessels, there is a need to investigate this
association in the context of PAD.
Accordingly, through this proposal the investigators seek to elucidate the relationship between Lmod1
and PAD. Specifically, they will determine the contribution and mechanism by which this gene regulates the
vascular biology of SMC dependent formation of mature neovessels, an attribute that may be critical in
regulating the pathogenesis of PAD. This proposal will bring together recognized experts from several fields to
complement the translational studies and unique mouse models proposed to thoroughly understand the role of
LMOD1 in PAD. In Aim 1, we will use cell culture models as well as state-of-the-art genomic and human
translational approaches to elucidate the mechanistic pathway by which reduced LMOD1 mediates impaired
neovessel maturation. In Aim 2, we will determine whether the LMOD1 mediated defect in neovessel
maturation and ultimately PAD is predominantly mediated through SMCs by performing advanced in vivo
survival surgeries on newly generated and available inducible SMC specific Lmod1 knockout mice and
importantly investigate whether the defect can be rescued. In Aim 3, using in vitro and in vivo approaches we
will investigate whether LMOD1-mediated defects in neovessel maturation may also account for increased
pathogenesis of PAD in type 2 diabetes mellitus (T2DM), a strong risk factor of PAD.
Taken together, this work will enhance the scientific community’s understanding on LMOD1 mediated
formation of mature neovessels, a critical regulator of PAD. The proposed work is relevant to the mission of the
NIH as it will lead to the development of new strategies and potential therapies to effectively treat patients
diagnosed with PAD.

Public health relevance
PROJECT NARRATIVE Relevance: Scientists do not yet completely understand the molecular basis of peripheral artery disease (PAD), a severe form of cardiovascular disease affecting 200 million people worldwide. Our preliminary studies identify a potential novel association between smooth muscle cell expressed gene, Leiomodin 1, and PAD. By understanding the underlying mechanism driving this potential association, our studies will likely lead to the development of new strategies and therapies to effectively treat this increasingly morbid and mortal pathological condition.